VGM: Vanderbilt Genomic Medicine Training Program

PROJECT SUMMARY
This application seeks to renew the Vanderbilt Genomic Medicine (VGM) training program at Vanderbilt
University Medical Center (VUMC). VGM fellows are trained in data science, bioinformatics, laboratory
science, and genomic discovery; the program also instructs fellows on the practice of genomic medicine. VGM
builds on decades-long strengths in critical enabling resources and infrastructure within VUMC including: 1)
BioVU, the largest biobank linking DNA samples to electronic medical records (EMRs) at a single academic
institution (now >244,000 subjects), 2) Participation in three NHGRI-funded networks: the Electronic Medical
Records and Genomics (eMERGE) network and eMERGE coordinating center, the Implementing Genomics in
Practice (IGNITE) Network, and the Undiagnosed Disease Network (UDN), 3) The Pharmacogenomic
Resource for Enhanced Decisions In Care and Treatment (PREDICT) project which embeds
pharmacogenomic testing within electronic health records (EHRs) to guide drug and dosage choices 4) a
Precision Oncology program that applies tumor genome sequencing to identify actionable mutations in cancers
and to personalized target therapy, and 6) the largest Department of Biomedical Informatics in the country, with
strong research, education, and support programs in clinical information technology. The program has 35
highly collaborative and well-funded faculty preceptors who team up to provide both basic and clinical research
opportunities to Ph.D.-level and M.D.-level postdoctoral fellows. Trainees will participate in rotations, seminars,
journal clubs, and retreats and interact with other clinical and research fellows and faculty. Under Vanderbilt’s
Biomedical Research Education and Training (BRET) Office, the program will provide Responsible Conduct in
Research (RCR) training, high-standard Individual Development Plans (IDP), and Career Development
programs with the goal of developing fellows to be next-generation leaders in genomic medicine. A Scientific
Advisory Committee and an External Advisory Committee provide valuable advice on VGM program
development and enhancement. The program actively seeks candidates from diverse populations and
professional and research backgrounds. Our fundamental model is to enhance multidisciplinary training
through a curriculum tailored for each trainee based on prior experience, coupled to paired mentoring to
provide both clinical and methodological expertise.

Public health relevance
PROJECT NARRATIVE Rapid advances in laboratory technology and digital healthcare have created a new discipline that uses genetic information to individualize patient care. The Vanderbilt Genomic Medicine (VGM) Training Program at Vanderbilt University Medical Center trains MD and PhD post-doctoral fellows to become knowledgeable with the science and practice of genomic medicine. The program teaches research design and analytic techniques with the ability to apply these methods in a clinical setting to advance patient care.